Integrative biophysical modeling for collective tissue mechanics

Project Summary/Abstract
Organ surfaces are covered with epithelial cells or endothelial cells, providing physical barriers for organs and
bodies. Cells on these confluent layers often remain static and non-migratory. However, they can also undergo
active structural rearrangements during basic physiological processes ranging across embryonic development,
morphogenesis, repair, and remodeling. In each of these events, an epithelial collective necessarily undergoes
a transition from a solid-like state which is quiescent and non-migratory to a fluid-like state which is dynamic and
migratory. This striking transition between non-migratory versus migratory behaviors is traditionally studied in
the context of cells on a flat surface in 2D. These collective cellular behaviors have been widely explored in
monolayers of epithelial cells that form two-dimensional (2D) flat surfaces, from both biophysics and cell biology
perspectives. However, they are not well-adapted to make predictions for natural epithelia, which are typically
found to form highly curved surfaces, where the radius of curvature can be comparable to a few cell lengths.
Epithelial tissues also comprise various topologies – spheres, ellipsoids, tubes, and saddle points — in native
structures such as embryos, alveoli, airways, vessels, and branching bifurcations. How surface curvature affects
the way a cell collective moves remains largely unknown; furthermore, how cells become jammed and unjammed
during the maturation of a cell monolayer growing on a curved surface remains unclear. Further, whereas
previous modeling efforts have focused more on the mechanics and migratory behavior of cells within a single
monolayer, the mammalian epidermis is a multilayered epithelial tissue. Although the developing epidermis is
highly dynamic, the time-dependent mechanics (i.e., rheology) of epidermal development remains elusive. There
are two key unresolved questions: (1) what cues drive epidermal development, and (2) how does the mechanics
of the epidermis depend on the timescale of measurement? There is an urgent need to develop theoretical and
computational models for these critical scenarios. I will develop an integrated computation modeling framework
to elucidate the biomechanics of collective cell behavior beyond the conventionally studied two-dimensional
settings, including curved surfaces and multilayered 3D epidermis. I will also create a novel model that addresses
the biomechanical couplings between nuclear morphologies and epithelial proliferation.

Public health relevance
Project Narrative Past computational and theoretical models for the biomechanics of multicellular systems have mainly focused on the collective cell behavior in flat two-dimensional monolayers. However, organ surfaces are covered with epithelial cells that are naturally curved and comprise of 3D multilayered structures. The proposed project will develop new concepts and quantitative physical models to provide an integrative biophysical understanding of: (1) collective cell behavior on curved geometries, (2) biomechanical model for the epidermis, and (3) the role of dynamically accessible nuclear morphologies in regulating epithelial proliferation.